Administrative Supplement for a Basic 3D-microfabrication System with Piezo 100 microns - MicroFAB-3D.B

This is a request for an equipment supplement on award R35GM142763.

Public health relevance
This is a request for an equipment supplement on award R35GM142763.